Patient-oriented research and mentoring in preterm birth toxicogenomics

PROJECT SUMMARY
This K24 proposal builds on over a decade of clinical and translational research – which the candidate – Dr.
Tracy Manuck, MD, MSc, has focused on spontaneous preterm birth (SPTB). In this application, Dr. Manuck has
recruited a team of multidisciplinary faculty experts to collaborate and support her in this endeavor, one that
reflects the breadth and depth of UNC’s resources in environmental research. This work will greatly augment her
current portfolio in patient-oriented research, allowing her to expand her current work and incorporate
environmental contaminants into her current R01 funded study (R01-MD011609), creating a rich, multi-
dimensional dataset. Candidate: Dr. Manuck is a recognized thought leader in the pharmacogenomics of SPTB.
She has won numerous national accolades and has led high-impact clinical prematurity studies; here, she seeks
to complement these skills by incorporating toxicogenomics into her research. Mentoring Plan/Environment:
Dr. Manuck has an established track record in research training, including serving as Maternal Fetal Medicine
(MFM) fellowship research director and a small group instructor for 2 graduate-level grant writing courses for
fellows and junior faculty. However, competing administrative and clinical responsibilities limit her available time
for mentorship. K24 award support will enable a more comprehensive mentoring portfolio within prematurity, and
help to develop the critical mass of researchers investigating reproductive health effects of environmental
contaminant exposure that is urgently needed in this field. With K24 support, she will have the appropriate time
and resources to mentor advanced trainees (e.g., postdoctoral fellows, junior faculty) in their pursuit of
independent funding. Dr. Manuck will leverage UNC’s extensive resources to accomplish this goal, including
NIH-funded centers and training programs, networks and collaborations, and global health institutes. Career
Goals and Objectives: Dr. Manuck will accomplish the following career development aims, including: Career
Aim 1 - Expand knowledge of environmental health; Career Aim 2 - Improve mentorship skills; Career Aim 3 -
Strengthen the ability to disseminate scientific results. Research Plan: Dr. Manuck will leverage her R01 study
(currently recruiting) to evaluate the effects of exposure to pro-inflammatory environmental contaminants as an
additional key driver of SPTB. She will integrate mentorship across the research aims: Aim 1 – Quantify exposure
to environmental contaminants during pregnancy through self-report and biomonitoring of maternal urine, serum,
and placentas; Aim 2 – Determine which contaminant or combination of contaminants is most strongly associated
with SPTB; and Aim 3 – Test the effects of gene x environment interactions on recurrent SPTB risk. This plan
offers a framework for Dr. Manuck’s training in the incorporation of environmental contaminants into prematurity
studies, with potential for lifelong impact on the >450,000 babies delivered too soon in the US each year, while
simultaneously providing a platform for mentoring future investigators committed to patient-oriented research.

Public health relevance
PROJECT NARRATIVE Dr. Manuck proposes a plan to integrate pro-inflammatory environmental exposures into her current prospective, longitudinal high risk preterm birth cohort. She will use this as a platform to further develop her own research skills and expand her significant mentoring of aspiring clinical researchers to improve the care of women at highest risk for prematurity. This project is relevant to the core mission of NIEHS because it uses patient-oriented research to better quantify the burden of environmental contaminant-induced prematurity and advance environmental health sciences.